Deciphering the immunomodulatory functions of phosphatidylserine in the tumor microenvironment

PROJECT SUMMARY / ABSTRACT
The tumor microenvironment (TME) is a complex assembly of cells, stromal tissue, and extracellular matrix
that collectively create physical, biochemical, and immune barriers to cancer therapies. Phosphatidylserine (PS), a
phospholipid typically confined to the inner leaflet of the plasma membrane, is believed to play a central role in the
immunosuppressive characteristics of many TMEs. Aberrant exposure of PS on tumor cell membranes has been
associated with negative prognoses and resistance to various treatments. This project seeks to understand this
aberrant PS exposure with the ultimate goal of finding ways to overcome the challenges that currently limit its clinical
exploitation. The central hypothesis of this proposal is that the exposure of PS on live (non-apoptotic) tumor cells
contributes to immune suppression via its interaction with neighboring cells, including tumor associated macrophages.
In Aim 1, the molecule(s) responsible for non-apoptotic PS exposure on tumor cells will be identified and their impact
on tumor progression and immune responses in syngeneic mouse tumor models will be determined. Preliminary data
implicate TMEM16F, a caspase-independent lipid scramblase, in non-apoptotic PS exposure on tumor cells. In Aim
2, the direct roles that PS plays in the immune-suppressive polarization of tumor-associated macrophages will be
defined. Chimeric receptors for efferocytosis (CHEFs) will be used to either amplify or reprogram tumor-associated
macrophage responses to PS recognition. Understanding the key molecular players and downstream immune
responses to externalized PS could reveal new therapeutic strategies to target PS in tumors and thereby improve the
immune system’s ability to attack solid tumors.
During the course of this fellowship, the applicant will hone a comprehensive skill set encompassing technical
expertise, sophisticated analytical skills, and effective communication, all of which will be essential for a career as an
independent clinician investigator studying tumor immunology. Under the guidance of Dr. Kodi Ravichandran, a
renowned expert in immunological responses across many disease states, and supported by a network of leading
cancer biology and immunology experts, the applicant is well-positioned for achieving her career goals. The
applicant’s institution, Washington University School of Medicine has a proven record of helping physician-scientists
build successful careers. This proposed training plan is designed to facilitate the applicant’s transition into a pediatric
oncologist and independent investigator dedicated to devising innovative therapeutic approaches for pediatric
cancers.

Public health relevance
PROJECT NARRATIVE Every year, two million new cases of invasive cancer are diagnosed in the United States, with solid tumors accounting for roughly 90% of these incidences. Many of these solid tumors do not respond to immunotherapies in part due to the immunosuppressive microenvironments they create. By exploring tumor cell exposure of phosphatidylserine (PS), an immunosuppressive signal, and the recognition of PS by tumor-associated macrophages, this project aims to unravel the complex mechanisms by which PS influences immune tolerance in order to identify novel therapeutic strategies to enhance anti-tumor immune responses.